SURMOUNTING WITHDRAWAL TO INITIATE FAST TREATMENT WITH NALTREXONE (CTN-0097). DSC5 CONTRACT. 09/20/2019 - 11/23/2021. N01DA-19-2250.

SURMOUNTING WITHDRAWAL TO INITIATE FAST TREATMENT WITH NALTREXONE (CTN-0097).